Molecular and Network Analyses of Lewy Body Dementia Pathogenesis

Project Summary / Abstract
Lewy body dementia (LBD), which includes Parkinson disease dementia (PDD) and dementia with Lewy
bodies (DLB), is a major form of Alzheimer disease (AD)-related dementia, accounting for up to 30% of all
dementia cases. Patients with LBD suffer from cognitive impairment, neuropsychiatric symptoms, and a
fraction of LBD patients have Parkinsonian motor symptoms. Clinical differentiation of DLB from PDD is
based on an arbitrarily defined “one-year rule”, and whether DLB and PDD are the same or different clinical
syndromes remains unclear. Our current knowledge of the molecular commonalities and differences in the
pathogenesis of these two LBD subtypes is limited. Furthermore, LBD is underdiagnosed, due to the low
sensitivity of the clinical diagnosis criteria and challenges in clinical differentiation of LBD from AD. Despite
the overlap in clinical symptoms between LBD and AD, there are key differences between LBD and AD
patients in the responses to antipsychotic drug treatment. The molecular basis of the phenotypic overlaps
and dissimilarities between LBD and AD is unknown. Currently, there is no reliable biomarker for LBD
diagnosis and no effective means of prevention or disease-modifying treatment, highlighting the need to
better understand the pathogenesis of LBD. This project will use an innovative approach of integrative
proteomics, glycoproteomics, and glycomics coupled with network analyses to address the following key
questions: What are the molecular abnormalities that define LBD? Do the two LBD subtypes (PDD and
DLB) have the same or different molecular abnormalities? How do PDD and DLB overlap with or differ from
AD at the molecular level? The proposed research will determine disease-associated changes in human
LBD brain proteome, glycoproteome, and glycome, identify molecular targets and pathways involved in
LBD pathogenesis, and elucidate LBD pathogenic mechanisms that are similar to or distinct from those of
AD. A variety of biochemical, cell biological, targeted glycoproteomics, and functional analyses as well as
animal model studies will be performed to validate and study the identified LBD-associated targets and
pathways. Findings from the proposed research will advance our knowledge of LBD pathogenesis and help
accelerate the effort to discover curative therapies for LBD as well as AD.

Public health relevance
Project Narrative Lewy body dementia is the second most common form of dementia in the elderly, with no effective means of diagnosis, prevention, or disease-modifying therapy. The proposed research will use an innovative approach and cutting-edge technologies to discover and study disease mechanisms and molecular targets for development of biomarkers and therapeutics to treat this debilitating dementia.